GENE THERAPY OF CANAVAN DISEASE

Treatment with a gene therapy approach for children with the childhood progressive leukodystrophy, Canavan's Disease, will be developed and characterized. This leukodystrophy results in profound psychomotor retardation and spongiform degenereration of the brain, and there is no specific treatment of the disease at present.